Bioanalytics and Proteomics Shared Resource

CORE 003 – BIOANALYTICS AND PROTEOMICS SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The mission of the Bioanalytics and Proteomics Shared Resource (BPSR) is to provide cost-effective, state-of-
the-art instrumentation and analytical expertise in mass spectrometry to investigators. The BPSR is centrally
located on the Vanderbilt campus and is composed of three components that provide the following analytical
services: 1) drug and metabolomics analysis, 2) comprehensive proteomics analysis and 3) molecular profiling
and tissue imaging. BPSR staff provide consultation on experimental design and sample preparation as well as
perform all aspects of mass spectrometry analyses and data analysis. LC-MS/MS, GC-MS and MALDI-TOF
instruments are available for small molecule, drug and metabolite analysis. LC-MS/MS instrumentation is
available for proteomics analysis, including multiple orbitrap systems. A variety of MALDI-based instruments are
provided for molecular profiling and tissue imaging experiments. In addition, inductively coupled plasma mass
spectrometry (ICP-MS) capabilities are offered for elemental analysis and tissue imaging. Specific services
include identification and quantification of small molecules in biofluids and tissues, identification and
quantification of proteins and their modifications by either stable isotope labeling (SILAC and TMT/iTRAQ) or
label free methods, crosslinking and hydrogen-deuterium exchange for protein-protein interaction analysis and
imaging of small molecules and proteins in tissues using imaging mass spectrometry. The BPSR staff provide
education and training in sample preparation, instrument-based experiments and data analysis to VICC
investigators and their laboratory personnel. Lastly, the BPSR collaborates with VICC investigators to continue
to offer the latest cutting-edge technology and methods in biomolecular mass spectrometry analysis for high-
impact cancer discovery.

Public health relevance
CORE 003 – BIOANALYTICS AND PROTEOMICS SHARED RESOURCE PROJECT NARRATIVE Per the PAR-13-386 FOA, the project narrative is not applicable for the Bioanalytics and Proteomics Shared Resource.